Cross-disciplinary Training in Immunology, Inflammation and Infectious Disease

PROJECT SUMMARY
Interdisciplinary research in Immunology, Inflammation and Infectious Disease affects a wide variety of human
diseases and has been fostered at the University of Utah via a campus-wide research initiative. In connection
with these efforts, the Immunology, Inflammation and Infectious Disease (3i) Training Program seeks to bring
together faculty and trainees across the University of Utah Health campus to foster collaborative research in
basic and translational immunology. This application is the recipient of substantial institutional backing and
requests support for 5 pre-doctoral trainees. The main component of the 3i Training Program is individualized
research training under the guidance of 37 well-funded faculty members in 8 departments across campus,
comprising 11 research divisions. Pre-doctoral trainees who have completed their qualifying exam are eligible
for up to 2 years of support. Trainees are selected by the Steering Committee from a large and highly competitive
pool of candidates based on prior research excellence, a research proposal and letters of recommendation. It
is anticipated that as part of their normal graduate education, trainees will complete their coursework, participate
in seminars and retreats, present their research in departmental settings, write a thesis proposal, perform thesis
research, publish results and defend their thesis research. In addition, the Training Program will enhance
graduate education through the following activities: 1) a one-month immunology rotation at ARUP, the national
pathology reference laboratory affiliated with the University of Utah; 2) formal training in grant-writing, leading to
submission of an extramural grant proposal; 3) support for travel to present data at scientific meetings; 4) monthly
publishing workshop with other Training Program trainees and mentors; 5) interaction with invited seminar
speakers; 6) annual presentation of research at the M&I retreat or 3i symposium; 7) guidance in the effective
utilization of Individual Development Plans (IDPs); and 8) formal mentoring in research ethics, including the
design and implementation of rigorous and reproducible research projects. Given the exceptional training track
record of our faculty, available resources to support research and robust institutional support, the 3i Training
Program will provide an ideal platform to train the next generation of human disease-focused immunologists.

Public health relevance
PROJECT NARRATIVE Immunology is an interdisciplinary science with direct relevance to many human diseases, including infectious diseases, autoimmune diseases, inflammatory diseases, immunodeficiency diseases and cancer. The training of immunology-focused researchers will meet a growing challenge to understand and exploit the immune system to treat human disease. The Immunology, Inflammation and Infectious Disease (3i) Training Program will guide the development of the next generation of immunology researchers with the appropriate experience and knowledge to meet this challenge.